A randomized comparative effectiveness trial of nicotine pouches for cigarette substitution: A question of public health

PROJECT SUMMARY
Commercial cigarette smoking is a modifiable risk factor implicated in one-third of all cancer deaths. Nicotine is
the chief addictive agent causing sustained smoking, but diverse tobacco products (e.g., e-cigarettes, FDA-
approved nicotine replacement) allow nicotine self-administration on a continuum of harm. Public health gains
could be substantial if people who use the most harmful products (i.e., combusted cigarettes) switch to a less
harmful nicotine product. Nicotine pouches – microfiber sachets containing powered nicotine but no tobacco
leaf – are a new class of oral tobacco products rapidly growing in popularity. Switching from cigarettes to
nicotine pouches is likely to be health-promoting because pouches are not combusted and contain fewer
harmful and potentially harmful chemicals than other tobacco products. However, we currently know very little
about how readily people who smoke will adopt nicotine pouches, how effectively pouches can substitute for
cigarettes when smokers are trying to avoid smoking, the importance of nicotine dose in effective cigarette
substitution, and the mechanisms that may promote or hinder product transition. To address these key gaps,
we will enroll 284 adults who smoke daily and are not planning to quit in the next 30 days in a randomized
controlled trial (RCT). Participants will be randomly assigned to receive: 1) 3-mg nicotine pouches; 2) 6-mg
nicotine pouches; 3) nicotine mini-lozenges (2- or 4-mg); or 4) no study product. Participants receiving a study
product (nicotine pouches or nicotine mini lozenges) will be asked to use them for 4 weeks, an initial
experimentation week, and then for a 3-week switching trial where they will be asked not to smoke their usual
cigarettes and instructed instead to use their study product (if assigned one). Before and after the switching
trial, participants will come to the clinic following overnight abstinence and will use their assigned product (if
any) during a 30-minute sampling test to assess the duration of product use, subjective evaluations of study
products, and suppression of craving and withdrawal symptoms under controlled conditions. During the 4
weeks of the study, participants will use a smartphone app to record, in real-time, each time they use
cigarettes (primary outcome) or a study product. For a random daily subset of use events, participants will
answer additional questions about the context of their use (e.g., affect, any restrictions on smoking) and
potential mechanisms driving use (e.g., withdrawal alleviation, satisfaction). Participants will also complete 3
daily prompted random assessments to characterize non-use contexts. This innovative, rigorous, and timely
research will provide critical information regarding: (a) the potential impact of providing nicotine pouches on
smokers’ use of combusted cigarettes, (b) whether nicotine dose influences the ability of pouches to replace
cigarette use, (c) whether pouches substitute for cigarettes more effectively than FDA-approved nicotine mini
lozenges, and (d) product usage patterns and effects that may promote or hinder cigarette substitution These
data could inform regulatory policy decisions regarding the potential public health impact of nicotine pouches.

Public health relevance
PROJECT NARRATIVE Public health gains could be substantial if people who use combusted cigarettes, the most harmful nicotine delivery products, switch to a less harmful nicotine product. This research will examine the ability of 3-mg and 6-mg nicotine pouches to serve as a replacement for cigarettes during a 3-week switching trial and compare them to nicotine mini lozenges or no-study product. This data could inform regulatory policy decisions regarding the public health impact of nicotine pouches.